Core D: Genomics and Proteomics

PROJECT SUMMARY- CORE D
Core D offers world-class genomics and proteomics services to the members of the Program. The Next
Generation sequencing facility was strongly supported by CSHL during the last five years, and it has extended
its capability in short (Illumina HiSeq2500, MiSeq and NextSeq) and long read technologies (Pacific Biosciences,
Oxford Nanopore). Core D offers an extensive array of sequencing applications, including but not limited to RNA-
Seq, Iso-Seq, whole genome sequencing, targeted sequencing (exomes, gene set, and amplicons), ChIP-Seq
and single-cell sequencing. For proteomics, the Core offers protein identification, protein complex identification
following IP, quantitative proteomics with iTRAQ and a panel of small molecule and metabolite screens. The
Core will continue working with members to develop new sequencing and proteomics applications, including in
the area of long sequencing reads and single-cell sequencing, The Core will also offer experimental design
support, sequencing project management and sequencing QC analysis to the investigators.

Public health relevance
PROJECT NARRATIVE - CORE D Genomics and proteomic are essential tools in cancer research. Core D provides services in DNA sequencing to identify changes in gene expression, epigenetics and DNA mutations driving the growth and maintenance of cancer. Mass spectrometry identifies proteins bound to essential cellular complexes, deepening our understanding of cancer cell growth and gene regulation.